Telomere and telomerase evolution in S. cerevisiae

PROJECT ABSTRACT
Telomeres, composed of repetitive DNA sequences at the termini of linear
chromosomes, serve as protective caps. However, telomeres cannot be fully
copied during replication without the ribonucleoprotein enzyme telomerase.
Understanding the delicate balance between telomere length and telomerase
activity has important implications for two of the biggest human health concerns:
aging and cancer. Telomeres have been shown to shorten with age, acting as a
“biological clock” limiting the rounds of division a cell can undergo. To circumvent
this proliferative limit, over 85% of cancers aberrantly up-regulate telomerase
expression. The long-term goal of this work is to understand the evolution of
telomeres and telomerase, and how these cellular components contribute to the
health and lifespan of an organism. To begin unraveling these broad fundamental
questions, two specific lines of inquiry will be undertaken harnessing the powerful
genetic manipulability of Saccharomyces cerevisiae. First, a screen for gain-of-
function mutations in telomerase RNA will identify novel alleles that lengthen
telomeres by increasing enzyme activity. Such gain-of-function mutants will shed
new light on how the essential RNA component of telomerase contributes to the
overall action of the enzyme. More active telomerase will also permit exploration
of whether longer telomeres alter total fitness of the organism. Second, yeast
strains will be genetically engineered to circularize each of their 16 linear
chromosomes, allowing novel experimental investigation of the advantages and
disadvantages of circular chromosomes in a eukaryotic organism. These novel
yeast strains will build a foundation for creating an innovative eukaryotic
organism with all linear chromosomes circularized, opening the door to explore
big picture questions of telomere and telomerase evolution.

Public health relevance
PROJECT NARRATIVE/PUBLIC HEALTH RELEVANCE Telomeres are repeated sequences at the ends of linear chromosomes that act as biological clocks, shortening as cells divide and preventing the uncontrolled cellular proliferation seen in cancers. The evolutionary costs and benefits of telomeres, and the telomerase enzyme that maintains their length, are not fully understood. This work aims to experimentally address fundamental questions regarding the mechanism of telomerase enzyme function and the necessity of linear chromosome structure, which will shed light on the basic biological underpinnings of both aging and cancer.